Alleviating tinnitus and memory deficits induced by blast exposure

Abstract
Tinnitus and mental illness are common disorders in veterans caused by blast exposure. Convergent evidence
found that tinnitus response is highly affected by the limbic impairment which may affect neurogenesis and
memory deficits. Although management of emotional and mental status has become a critical treatment for
tinnitus, the connection of tinnitus and memory deficits has rarely been studied. Our preliminary study found
that blast exposure can induce neural inflammation in the auditory brainstem and reduced neural neurogenesis
in the hippocampus. We hypothesize that blast caused damage in the auditory and limbic system is critical in
exacerbating the severity of chronic tinnitus, and reducing the neural damage in the limbic system will rescue
memory deficits and alleviate tinnitus. Three specific aims of this study are: (1) To determine the correlation of
blast waves induced memory deficits and chronic tinnitus/hyperacusis. In our preliminary study we have shown
tinnitus, hyperacusis and impaired memory retention deficits induced by blast exposure in our animal model.
We will continue to investigate the cause and correlation of these disorders and determine if memory
impairment will increase the likelihood of developing chronic tinnitus/hyperacusis; (2) To identify whether blast
exposure activates brain immune cells in the central auditory system and disturbs ongoing adult neurogenesis
in the hippocampus. In our preliminary study, we found that blast exposure impaired adult neurogenesis and
activated brain immune cells in the auditory brainstem and the hippocampus. In this study, we will determine the
neural pathway of blast waves induced neural inflammation and neurogenesis. Immunostaining of neural
inflammation and neurogenesis markers will be used to detect blast induced neural impairment blasts; (3) To
determine if improving neuron survival using minocycline, a sage tetracycline derivative, can reduce
neuroinflammation in the brainstem and hippocampus and reduce chronic tinnitus and memory deficits after
blast. We predict that treatment of minocycline will reduce brain inflammation, memory deficits and
tinnitus/hyperacusis in the blast exposure animals. In summary, this project will address tinnitus and mental
illness caused by blast wave injury. The success of this study will provide neural mechanisms and clinically
relevant data on ameliorating these auditory disorders and memory deficits.
[Type here]

Public health relevance
Narrative Tinnitus and memory deficits are common disorders induced by blast-induced traumatic injuries in veterans. In this proposal, blast-induced tinnitus and memory deficits will be evaluated using animal models. Reducing neuroinflammation and rescuing neurogenesis using minocycline will be tested to alleviate chronic tinnitus and improve cognitive function induced by blast exposure.